Midcareer Investigator Award in Patient-Oriented Research in Pediatric Asthma

The candidate is currently a Professor of Pediatrics and Environmental Medicine and Climate Science at the
Icahn School of Medicine at Mount Sinai and a clinical investigator and epidemiologist whose research
investigations are thematically linked through their focus on delineating prenatal and postnatal determinants
of asthma and lung function to inform efforts to increase protective exposures, decrease adverse exposures,
and inform prevention efforts. Prenatal and early childhood environmental exposures have the potential to
have lifelong effects on respiratory health. The candidate's current patient-oriented research investigations
include prenatal exposures such as maternal nutritional exposures and air pollution and she proposes to
expand to investigations of multilevel postnatal environmental exposures and child asthma in novel cohorts.
The candidate has developed a plan to increase and strengthen her skills in both patient-oriented research and
mentoring through expansion of formal research mentor training efforts. The candidate proposes a mentoring
plan for trainees to facilitate their effective transition from junior clinical investigator to independent
investigators.

Public health relevance
Asthma is common in childhood and a growing body of evidence suggest that pre-and postnatal exposures play a role in asthma inception and morbidity. Neighborhood-level social and ambient environmental factors are important exposures that are not commonly measured and incorporated into investigations of asthma. The aims of this study will be met by allowing the candidate to mentor new clinical investigators in patient-oriented research and conduct studies of prenatal and postnatal environmental exposures, in a research program that serves to delineate protective and risk factors and mechanisms of disease for asthma prevention.